Developing InnoVative Equity-focused Regulatory SciencE (DIVERSE)

Project Summary/Abstract
Advancing health equity through diversity in clinical trials and other regulatory science research can be
achieved with diverse community-based recruitment sites when amplified with innovative application of the
science of engagement and appropriate community infrastructure. This proposal builds on The University of
Maryland Baltimore (UMB) PATIENTS Program’s decade of advancing health equity research and the science
of engagement in collaboration with established community-based organization (CBO) partnerships with (1)
Walgreens, the nation’s second largest network of community pharmacies and (2) Mt. Lebanon Baptist Church
(MLBC), an African American church that has been a longstanding partner of the PATIENTS Program.
Dr. Mullins and the PATIENTS Program have advanced the science of engagement, which builds upon
fundamental concepts of team science but expands the “team” to include non-traditional researchers, such as
patients, community-based providers, community health advocates, learning health system administrators, and
other stakeholders in scientific investigations. Including and engaging a more diverse team of stakeholders is
proposed as a means to incorporate multistakeholder perspectives that collaboratively and synergistically can
advance health equity. Before full scale implementation of diversity initiatives using CBOs, it is important to
produce a “proof of concept” to demonstrate the feasibility of CBOs to effectively identify, recruit, refer, retain,
and continuously engage patients and relevant stakeholders throughout the clinical trial. Our proof of concept
is achieved through simulation exercises of clinical trial and other health equity regulatory science studies in
CBO locations.
The proposed simulation exercises align with Dr. Mullins’ evidence based 10-Step Framework for Continuous
Patient and Stakeholder Engagement. Our simulation exercises are designed to assess whether and how to
partner with CBOs to achieve health equity to enhance diversity in clinical trials and other regulatory science
research. To achieve that overarching goal, we propose three Aims as follows: Aim 1: Collaboratively prioritize
health equity simulation scenarios to address health equity-related barriers and facilitators for
underrepresented populations’ enrollment in clinical trials and other regulatory science research in partnership
with 2 CBOs: community pharmacies and faith-based organizations; Aim 2: Conduct and evaluate health equity
simulation of enrollment in clinical trials and other health equity regulatory science research to test feasibility of
workflow in CBO settings as enrollment, retention, and dissemination sites for clinical trials and other
regulatory science research; Aim 3: Evaluate and prioritize action-oriented health equity activities to enhance
CBO capacity to address health equity-related barriers and facilitators and increase enrollment in clinical trials
and other regulatory science research by underrepresented populations.

Public health relevance
Narrative This proposal builds on The University of Maryland Baltimore (UMB) PATIENTS Program’s decade of advancing health equity research and the science of engagement in collaboration with established community- based organization (CBO) partnerships with (1) Walgreens, the nation’s second largest network of community pharmacies and (2) Mt. Lebanon Baptist Church, an African American church that has been a longstanding partner of the PATIENTS Program. Before full scale implementation of diversity initiatives using CBOs, it is important to produce a “proof of concept” to demonstrate the feasibility of CBOs to effectively identify, recruit, refer, retain, and continuously engage patients and relevant stakeholders throughout the clinical trial. Our proof of concept is achieved through simulation exercises of clinical trial and other health equity regulatory science studies in CBO locations.